Nf2-dependent regulation of neuronal scaling in the developing cerebellum

Summary
The production of different types of neurons in the appropriate proportions, called neuronal scaling, is critical
for the formation of functional neural circuits and proper excitatory/inhibitory balance. Disruption of neuronal
scaling contributes to the pathogenesis of developmental brain disorders, including spinocerebellar ataxia and
autism. Although significant progress has been made toward understanding the differentiation of specific
neurons, little is known regarding the mechanisms that scale the number of functionally related neurons in the
brain. The cerebellum contains only few neuronal cell types, the developmental origins of which are well-
established. Thus, the cerebellum is an ideal system to study the mechanisms of neuronal scaling. In the
cerebellum, both rhombic lip-derived excitatory granule neurons and ventricular zone-derived inhibitory
interneurons are scaled relative to Purkinje cells, the only output neurons from the cerebellar cortex. Purkinje
cells control the number of granule cells by secreting the Sonic hedgehog (Shh) protein, which promotes the
proliferation of granule cell precursors and the expansion of progenitors in the prospective white matter (pWM)
that give rise to inhibitory interneurons. Before migrating to the pWM, neural progenitors proliferate in the
cerebellar ventricular zone (cVZ), which also gives rise to Purkinje cell layer progenitors (PCLPs), which during
normal development produce exclusively glia. While Shh production by Purkinje cells and Shh transduction in
granule cell precursors has been studied intensively, the neuronal scaling mechanisms that act intrinsically in
cVZ-derived cells are poorly understood. In our preliminary studies, we found that loss of the
Neurofibromatosis 2 (Nf2) gene results in a unique phenotype with disrupted scaling of both granule cells and
inhibitory interneurons relative to Purkinje cells. Excitingly, our conditional knockout analysis in mice revealed
that Nf2 controls neuronal scaling in the cerebellum acting intrinsically in cVZ-derived cells to regulate several
distinct, poorly understood developmental steps. This proposal will characterize the molecular mechanisms
that regulate neuronal scaling in the cerebellum, using Nf2 as an entry point, in three complementary Aims. In
Aim 1, we will investigate how Nf2 coordinates the proliferation and migration of progenitors in the cVZ,
identifying novel Nf2 downstream targets that regulate each of these processes. In Aim 2, we will define an
Nf2-dependent pathway that regulates the expansion and proliferative response to Shh of pWM progenitors. In
Aim 3, we will identify Nf2-dependent mechanisms that inhibit the misspecification of PCLPs into granule cells,
preventing the production of excessive granule cells during normal development. Our studies will identify basic
mechanisms that regulate development of the cerebellum, a major center of motor coordination and cognitive
functions, will provide novel insights into human cerebellar developmental disorders, and help the development
of brain regeneration therapies.

Public health relevance
Project Narrative Disruption of cerebellar development is associated with a broad spectrum of neurological disorders, ranging from ataxia to autism, and common pregnancy complications, such as preterm birth and intrauterine growth restriction. By identifying the mechanisms that regulate the development and scaling of neuronal populations in the cerebellum, our studies will provide a foundation for understanding cerebellar disorders and the development of regeneration therapies for the human cerebellum, which is frequently affected by both genetic and non-genetic factors.